Neuroimmune mechanisms underlying electroacupuncture effect on vascular function

PROJECT SUMMARY Hypertension (HTN) is the most significant modifiable risk factor for cardiovascular disease and involves multiple pathways including those in the neuroendocrine and immune systems. Antihypertensive drugs manage HTN but do not address the central sympathetic and inflammatory pathways and approximately 50% of hypertensive (HTNive) patients do not have their blood pressure (BP) controlled. The World Health Organization has suggested acupuncture for HTN; however, prior clinical trials utilizing acupuncture have shown modest or null outcomes and have not achieved clinically meaningful reductions in BP. These conflicting outcomes result from the lack of a mechanistic approach to using electroacupuncture (EA), a form of neurostimulation. The reasons for inadequate treatment and BP control are complex, but one reason for this therapeutic misalignment may be an incomplete understanding of the mechanisms underlying the development and progression of HTN including autonomic dysfunction and chronic inflammation. Using neuroanatomical mapping, phenotyping, and recording of neurophysiological responses that correspond to neuromodulatory mechanisms underlying effects of EA, we successfully selected specific acupoints that in combination (or combined (c)EA) show complementary mechanisms of sympathoinhibition and parasympathoexcitation and not only reduce BP to clinically meaningful levels but also improve underlying autonomic dysfunction and low-grade inflammation. Our proposed study addresses one of NCCIH’s top priorities, “Determine and analyze the neural pathways by which acupuncture exerts its therapeutic effects.” Our strong preliminary data, from HTNive Dahl Salt Sensitive (DSS) rats, show that EA at our unique combination of acupoints, which simultaneously activate afferents in the median, tibial, and deep peroneal nerves then modulate CNS regulation by activation of neurons in the nucleus of tractus solitarius (NTS) and the dorsal motor nucleus of the vagus (DMV). This modulation resulted in an increase in descending peripheral parasympathetic activity. Treatment with cEA also reduced presympathetic neuronal and splanchnic sympathetic nerve activities. In this study, we will investigate if cEA treatment leads to BP reduction by improving autonomic tone and decreasing inflammation through the neural mechanistic pathways we have preliminarily discovered. Our main aim is to assess mechanisms of the BP lowering effect of cEA in HTNive animals and then validate the improvement in autonomic indices and inflammation by translating it in mild- moderative HTNive patients. We plan to achieve this by: 1) direct assessment of the effect of cEA on neurons in the hypothalamic and brainstem regions controlling parasympathetic and sympathetic balance including NTS, DMV, paraventricular nucleus (PVN), and rostral ventrolateral medulla (rVLM), as well as parasympathetic and sympathetic efferent activity; 2) investigating if cEA reduces inflammation and improves vascular function through acetylcholinergic receptors (AChR) activity in DSS HTNive rats; and 3) using a crossover design in a human randomized control study, primarily assess effects of cEA on physiological alterations in autonomic function and chronic inflammation and their mediating effect on vascular function and BP. If successful, this study would address the mechanistic basis for the effects of EA as a therapeutic option for HTNive patients who are not at optimal BP goals with conventional therapy alone.

Public health relevance
PROJECT NARRATIVE Electroacupuncture works by stimulating various nerves in the body, which can lead to lowering of blood pressure. In this study, we are looking at how a specific combination of nerve stimulation using electroacupuncture can improve the function of the arterial vessels that control blood pressure. Findings from this study may aid the design and delivery of electroacupuncture treatment to help those who are unable to get to their blood pressure to target levels.